Supp: Effects of Adolescent Alcohol Exposure on Hippocampal Function in Adulthood

The NADIA consortium is dedicated to identifying the mechanisms underlying the long-term effects of adolescent intermittent ethanol exposure (AIE) on brain and behavior and exploring approaches to prevent or reverse them. Component 1 has focused on the enduring effects of AIE on hippocampal structure and function and their behavioral sequelae. Based on our findings, our overarching hypothesis AIE causes an enduring but reversible compromise of hippocampal synaptic function driven by interacting epigenetic, neuroinflammatory, and glial mechanisms. During the last NADIA funding cycle we found that AIE produces a pro-inflammatory milieu in the hippocampal formation, alterations of dendritic spine density and morphology, altered histone acetylation and methylation, diminished astrocyte-synaptic proximity, decreases in neurogenesis, and increases in the mobilization cell death molecular machinery. Through NADIA collaborations, we further identified epigenetic changes that suggest specific molecular mechanisms underlying those effects. Importantly, we have also shown that many of those effects are reversible in adulthood with pharmacological agents in current clinical use. Our recent findings indicate that AIE results in a propensity toward anxiety-like behavior after environmental challenge, thus suggesting the need to expand our assessments to the ventral hippocampus. This has obvious translational implications because anxiety and stress reactivity are strong predictors of AUD development and relapse, and suggests that some of the AIE-induced changes we have observed in the dorsal hippocampus may be similar in the ventral region. This supplement to promote diversity in alcohol-related research capitalizes on our current work and collaboration with a Historically Black College & University, North Carolina Central University. This supplement expands our research in the parent grant Aim 2 to identify mechanisms underlying AIE-induced hippocampal inflammatory markers by determining the role of these inflammatory markers on hippocampal- associated memory tasks. Moreover, this supplement expands the research training, professional development, and scientific network of an underrepresented minority doctoral graduate student.

Public health relevance
Project Narrative Alcohol consumption by adolescents and young adults continues to be a substantive public health concern in the U.S. The hippocampus, one of the most alcohol-sensitive brain regions, is crucial for both memory and affective functioning. This supplement to increase diversity in alcohol-related research will identify specific biological mechanisms underlying those effects and assess several treatments that may prevent or reverse those effects on brain and behavioral function.